Uncovering the Inflammatory-Fibrotic Axis in Pulmonary Sarcoidosis

PROJECT ABSTRACT
Sarcoidosis is a systemic disease of unknown etiology that results in granulomatous inflammation which, if
persistent, can lead to fibrosis of involved organs and subsequent dysfunction. Advanced pulmonary
sarcoidosis-related fibrosis (APSF) occurs in up to 20% of those with pulmonary sarcoidosis and carries
significant morbidity and mortality. Existing transcriptomic studies within sarcoidosis highlight multiple
peripherally circulating dysfunctional cell subtypes and aberrant pathways that drive sarcoidosis inflammation;
however, knowledge of these mechanisms in the APSF phenotype is limited. Improved understanding of the
mechanisms by which dysregulated immunity contributes to APSF is critical to identify future therapeutic
strategies that benefit this vulnerable population. Our preliminary data suggest that subsets of circulating
CD14+ monocytes exhibit unique profibrotic programming in APSF compared to non-fibrotic disease, with
further profibrotic signaling originating from circulating central memory T cells and deserves further exploration.
By integrating current knowledge of sarcoidosis pathophysiology, emerging concepts in idiopathic
pulmonary fibrosis (IPF), and our compelling preliminary data, we aim to elucidate the mechanisms through
which circulating CD14+ monocytes drive the inflammatory-fibrotic axis of APSF. In Aim 1, we will use single-
cell RNA sequencing (scRNA-seq) and surface protein indexing to identify key regulators and corresponding
signaling pathways within subpopulations of CD14+ monocytes in individuals with chronic sarcoidosis, with
and without APSF. Key transcription factors (TFs) identified will be tested in an in vitro functional assay of
monocyte-to-fibrocyte differentiation to confirm their profibrotic effects. Aim 2 will define the external profibrotic
influences monocytes receive from TCM cells leveraging pathways uncovered by scRNA-seq through in vitro
methods of cell stimulation, co-culture, and differentiation assays. We anticipate that our findings will identify
novel mechanistic pathways involved in the progression of APSF that may be used for therapeutic targeting.
In addition, a complimentary career development plan has been proposed to achieve my goals of
becoming an independent investigator and future expert in pulmonary fibrosis immunology. Over the award
period, I will refine analytical techniques of large, multifaceted datasets and strengthen my expertise in
translating gained insights into biologically relevant in vitro models. Through this process, I will also advance
my skills in study design, statistical methods, and result dissemination, building a strong foundation for future
R01 funding as a independent physician scientist.
1 | Uncovering the Inflammatory-Fibrotic Axis in Pulmonary Sarcoidosis Christen Vagts, MD
Project Abstract and Narrative

Public health relevance
PROJECT NARRATIVE Fibrosis in advanced pulmonary sarcoidosis carries significant morbidity and mortality but the mechanisms whereby sarcoidosis inflammation contributes to fibrosis are poorly understood. We aim to determine immune pathways and key mediators by which circulating CD14+ monocytes contribute to fibrosis in individuals with advanced fibrotic pulmonary sarcoidosis (APSF). Our findings will inspire future research and facilitate development of targeted treatment strategies that will directly benefit individuals with APSF.